INSULIN RESISTANCE IN PATIENTS WITH PRECOCIOUS PUBERTY

The purpose of this study is to characterize changes in insulin resistance in children with precocious puberty and restudy them during reversal of pubertal progression using long-acting GnRH analogue to suppress gonadal function.